Trends of disparities in breast cancer progression and health care considering multilevel risk factors

Trends of disparities in breast cancer progression and health care
considering multilevel risk factors
Health disparities widely exist in the United States. African Americans and Hispanic
populations suffer disproportionally from cancer incidents and outcomes. There are
treatments and policies designed trying to improve health outcomes and reduce
disparities. Research methods are needed that help monitor the trend of health
disparities, evaluate efficiencies of interventions, identify risk factors that contribute to
the start and the change in health disparities, and quantify the effects of identified risk
factors.
In this study, we propose to develop modern analytical methods that address these
requests in research. We propose single- and multi-level moderation analysis methods
that adopt recently developed data mining and machine learning techniques in the
general mediation analysis. Using these methods, researchers will be able to
differentiate and make inferences on effects of risk factors on the observed health
disparities from both individual and environmental levels. In addition, we will be able to
identify changes of health disparities over time and over employment of new policies.
An R package will be developed for the implementation of the proposed novel methods.
We will demonstrate the method in 1) identifying the trend of racial disparity in using the
Oncotype diagnosis among eligible breast cancer patients, and identifying and making
inferences on effects of risk factors that contribute to the change of racial disparity over
time; and 2) Investigating the interactive effects of individual factors and social/physical
environments on explaining racial disparities in breast cancer outcomes in Louisiana.

Public health relevance
Narrative It is important to monitor the change in health disparities over years, to evaluate efficiency of interventions that aim at reducing health disparities and to identify changes in risk factors that contribute to the trend of the disparity or to the different efficiency of interventions on different populations. We propose to investigate the trend in racial disparity of using Oncotype diagnosis among breast cancer patients, and to monitor the joint effects of social and physical environments and individual behaviors in contributing to the racial disparities in breast cancer outcomes. For the proposed research, we plan to develop novel moderation analysis methods using data mining techniques that can help efficiently identify and differentiate risk factors in explaining health disparities and their changes over time.